Molecular mechanisms of protein function

Project Summary:
The goals of this research program are to understand the molecular mechanisms underlying proteins and
protein complexes that facilitate intracellular ion transport and ensure genomic integrity by replicating and
repairing the genome. For proteins involved in membrane transport, we aim to elucidate the mechanisms by
which ions are recognized and transported across the membrane as well as how the activities of these proteins
are regulated. For those involved in maintaining genomic integrity, we will address how genomic features are
recognized to recruit the replication and repair machineries to specific genomic loci. We employ a highly
collaborative approach, combining high-resolution structure determination, electrophysiology, in vitro
reconstitution, cell biology, computational analysis and mouse models to establish a holistic understanding of
these proteins and protein complexes at the molecular level and their how dysregulation can lead to disease.
We are currently focused on investigating four families of ion transport proteins including the lysosomal
potassium and proton channel TMEM175, the CLC family of chloride channels and transporters, the inositol
trisphosphate receptors and CLN7. TMEM175 is a lysosomal channel responsible for maintaining lysosomal
pH that is critical for lysosomal function and homeostasis. We are identifying novel inhibitors of TMEM175 to
better understand its physiological roles and determining how diverse stimuli coordinate to regulate its activity.
Humans express 5 CLC transporters in the endolysosomal system, where they regulate ion and pH
homeostasis. We are elucidating how lipids, accessory subunits and other stumuli regulate the activity of
CLCs. Inositol trisphosphate receptors are tetrameric channels that release Ca2+ stored in the endoplasmic
reticulum to stimulate diverse cellular pathways including fertilization, cell death and cell division. We aim to
understand how IP3Rs are regulated by their diverse stimuli and how these regulatory stimuli result in Ca2+
oscillations. CLN7 is a lysosomal chloride channel that more closely resembles transporters than channels. We
are investigating how CLN7 can selectively permeate chloride ions in the lysosome.
Genomic integrity requires that the genome be duplicated during each cell cycle without errors. We are
investigating how DNA structures, such as a G4-quadreplexes act as impediments to the DNA replication
machinery and how these impediments can be overcome to complete replication.
Collectively, these studies will reveal insights into protein function that will improve understanding of their roles
in critical physiological processes. As dysregulation of any of these components can lead to disease, these
studies will also provide insights into the molecular basis of disease.

Public health relevance
Project Narrative: This research aims to resolve the molecular mechanisms underlying proteins involved in intracellular ion transport and in ensuring genomic integrity. The ion transport proteins under study play critical roles in organellular homeostasis and cellular signaling pathways and their dysregulation is associated with a wide range of diseases including neurodegeneration, cancer and immune disorders, while the complexes we study that participate in genomic integrity are essential for faithfully duplicating the genome. The insights gained from this research will advance understanding into the molecular basis of disease and provide a platform for developing novel therapeutics.